Communicating for Health Equity in Digital Environments

ABSTRACT
Smoking is increasingly concentrated in socioeconomically disadvantaged populations that might not have
been reached by the policies and communication campaigns to the same degree as the more prosperous
groups. In the rapidly changing media landscape, new approaches to developing and testing messages are
needed. This project will use an innovative combination of qualitative, eye tracking, and quantitative (discrete
choice experiment, randomized clinical trial) studies to develop and evaluate tobacco education message
strategies delivered on digital channels that communicate complex scientific concepts to the public, particularly
the priority populations. These strategies will be developed in the context of the FDA-proposed ban on menthol
in cigarettes and flavors in cigar products (“flavor ban”). Flavor ban has the potential to save hundreds of
thousand of lives, but can be undermined by misinformation and misperceptions. Little research has
systematically documented the misperceptions or developed messages to correct them. Our project proposes
to address this important gap by developing and testing strategies to reach priority populations with messages
on digital channels. This project will provide that research by pursuing these specific aims: (1) Identify effective
message attributes for digital channels using a co-creation approach; (2) Quantify the relative importance of
different attributes of digital messages using a combination of a discrete choice experiment and an eye-
tracking study; and (3) Test the impact of messages on behavioral outcomes in a context of digital social media
in a randomized clinical trial with a nationally representative sample of flavored combusted tobacco product
users. The results will help eliminate tobacco-related disparities and increase the effectiveness of tobacco
educational messages among the population for whom anti-tobacco messages have not been optimally
effective.

Public health relevance
PROJECT NARRATIVE To address persistent disparities in combusted tobacco product use, novel communication approaches through digital channels are needed. Using an innovative combination of qualitative, eye tracking, and quantitative (discrete choice experiment, randomized clinical trial) studies, we will develop and test messages to reach low- SES smokers. Results will will help eliminate tobacco-related disparities and increase the effectiveness of tobacco educational messages among the population for whom anti-tobacco messages have not been optimally effective.